Training the next generation of clinical neuroscientists

The last decade has witnessed a surge in new research findings in neuroscience. So far, however, that
impressive progress has not translated into more effective treatments, or better outcomes, for patients with
serious mental illness. Although this may just be a matter of time, another contributing factor is the lack of
physician scientists in the field of clinical neuroscience. Physician scientists are uniquely capable of linking
basic science findings to the clinical phenomenology of psychiatric illness. Indeed, scientists like these - with
both clinical and research training - are uniquely poised to bridge the gap between basic neurobiology and
clinical disease. This combination is critical for advancing our understanding of the neurobiology of psychiatric
disorders - and for developing the highly needed disease-modifying treatments for psychiatric illnesses.
One of the explanations for the lack of clinician-scientists is the difficulty in obtaining grant funding right after
residency. This proposal aims to fill that gap. In a two-three year fellowship we will provide intense research
training for a select group of psychiatrists (or PhD psychologists). Upon completion, trainees should be able to
apply successfully for individual grants and develop into independent clinical neuroscientists. We aim to create
clinician-researchers who can combine clinical knowledge with superior research skills. The long-term goal is
to help shape the new generation of leaders in clinical neuroscience. Drs. Kahn, Malaspina and New are each
renowned physician scientists who combine clinical expertise with deep research and training experience.
This program will fill an important gap in the otherwise impressive translational research program at the Icahn
School of Medicine at Mount Sinai (ISMMS), recognized as a top ten innovative research engine worldwide by
Nature. Indeed, the Departments of Neuroscience and Psychiatry are ranked #1 and #6 respectively in NIH
funding. We already have extensive experience, and a successful track record, in supporting other research
career pathways, including a Physician-Scientist residency research track for MD, PhD trainees, and the first
Combined Psychiatry Residency and PhD Training program in the US, funded by an NIMH R25 grant, of which
Dr. New is PI. We also have 6 K awardees and 2 K99/R00 investigators in our rich training programs.
The proposed T32 fellowship program is designed to train psychiatrists and clinical PhDs to formulate original
research questions on etiology, pathogenesis, course, treatment and prevention of serious mental illness. Its
focus is on patients with schizophrenia and major mood disorders. Each trainee, paired with a mentor, will
formulate a career development plan with targeted goals for acquisition of skills, presentations, publications,
gathering pilot data, and preparation of proposals for external funding - usually a career development award.
Regular meetings, internally and with an external advisory board, will monitor trainee development in relevant
milestones. We aim to help fill the dearth in clinical neuroscientists so that the recent advances in
neuroscience can be translated into better care for the millions of patients with serious mental illness.

Public health relevance
Project Narrative The proposed T32 fellowship program is designed to train psychiatrists and clinical PhDs to formulate original research questions on etiology, pathogenesis, course, treatment and prevention of serious mental illness, with a focus on patients with schizophrenia and major mood disorders. Each trainee, paired with a mentor, will formulate a career development plan with targeted goals for acquisition of skills, presentations, publications, gathering pilot data, and preparation of proposals for independent research funding. We aim to help fill the dearth in clinical neuroscientists so that the recent advances in neuroscience can be translated into better care for the millions of patients with serious mental illness.